Living Yeast Sense-Respond Therapeutic Communities Engineered with Synthetic Biology

Contact PD/PI: CORNISH, VIRGINIA W
Project Summary
The objective of this proposal is to broaden the capabilities of current synthetic biology tools by specifically
focusing on yeast as biosensors, therapeutics, and as sense-and-respond communities. Living cells are
positioned to be one of the next transformative technologies for therapeutic treatment. Rather than giving a
purified small molecule or a purified protein as the drug, the living cell, in this case yeast, can be applied in situ
at the site of disease that will continuously produce the necessary therapeutic. There are many advantages to
using living yeast, as opposed to bacteria or mammalian cells as the in situ therapeutic, as they are cheap, easily
scalable, easy to store, and Saccharomyces cerevisiae arguably has the most powerful genetic and synthetic
biology tools for cell engineering. This project involves several different arms working in tandem: we plan to
develop yeast that can sense different bacterial infections in wounds, yeast that can secrete different antibiotics
in wounds, and finally yeast that secrete specific antibiotics in response to the bacteria present in the wound. This
research combines our expertise working with antibiotics and wound healing to become a more sophisticated
method of disease treatment. Yeast that can sense bacterial infections and secrete different antibiotics ultimately
can be broadly applied beyond wound healing. The sensing and therapeutic approaches developed here should
be broadly enabling in the longer term for making yeast sense-respond communities for treating human disease
beyond bacterial infections and antibiotics.
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: CORNISH, VIRGINIA W Project Narrative The goal of this application is to develop broadly enabling synthetic biology tools and strategies for engineering yeast biosensors, yeast therapeutics, and yeast sense-respond communities. To meet this goal, we plan to develop yeast that can sense different bacterial infections in wounds, secrete different antibiotics in wounds, and finally can secrete specific antibiotics in response to the bacteria present in the wound. Project Narrative Page 7